Epigenetic insights into stress vulnerability in mouse models

Abstract
While neuropsychiatric disorders are highly heritable, it is well recognized that environmental
factors, such as chronic stress, contribute to the risk of developing mood-related psychiatric
disorders. However, the epigenetic mechanisms underlying stress vulnerability and the
pathogenic mechanisms linking stress to increased susceptibility of psychiatric conditions are
not well understood. Based on our recent discovery that the transcription factor Yin Yang 1
(YY1) and YY1 regulon are selectively down-regulated in cortical excitatory neurons upon
chronic stress exposure, and selective ablation of Yy1 in excitatory neurons enhances stress
sensitivity in both male and female mice, we propose to employ a combination of genetic,
genomic, molecular, and behavioral approaches to investigate the epigenetic mechanisms by
which chronic stress elicits maladaptive behaviors and test a specific hypothesis that the stress
related glucocorticoid receptor (GR)-YY1 reciprocal regulation contributes to stress vulnerability
in mice. With currently available state-of-the-art genomic technologies and our newly
developed, genetically modified mouse tools, we hope to improve our understanding of the
underlying causes of stress-related psychiatric disorders and provide the necessary foundation
for better diagnosis and intervention.

Public health relevance
Narrative According to a recent estimate by the National Institute of Mental Health, each year about 6.7% of adults in the U.S experience major depressive disorders, and women are 70% more likely than men to experience depression during their lifetime. Currently, the treatment options are limited with low efficacy. The underlying cause of this neuropsychiatric condition is complex, likely involves gene-environment (under the influence of adverse life events and stressful experience) interactions. Thus, we propose to understand the biological consequence of chronic stress exposure and how those stressful experience alters stress vulnerability and leads to maladaptive behaviors in animal models. An improved understanding of the cause of stress-related psychiatric disorders will lead to improved treatments and diagnostic tests - a high priority for the National Institutes of Health.